RADIATION THERAPY ONCOLOGY GROUP

{\rtf1\ansi\ansicpg1252\deff0\deflang1033{\fonttbl{\f0\fswiss\fcharset0 Arial;}} {\*\generator Msftedit 5.41.15.1515;}\viewkind4\uc1\pard\f0\fs20 The Radiation Therapy Oncology Group (RTOG) is the leading multicenter and multidisciplinary research\par organization systematically testing novel radiotherapy (RT) approaches against cancer and pursuing fully\par integrated translations! research to enhance this effort. The group will build on its outstanding scientific\par accomplishments in the current funding period to conduct research based on three fundamental initiatives: 1.\par Physical Targeting: RTOG will implement and test advances in imaging and high-precision RT planning and\par delivery technologies in clinical trials. 2. Molecular Targeting: Combined with RT: RTOG will design and\par conduct hypothesis-driven trials testing the integration of novel molecular targeted anti-cancer agents with\par optimized RT or chemo-RT. 3. Translational Research: RTOG will implement powerful biostatistical and\par medical informatics approaches to its unique and inter-linked clinical, biophysical, biologic, and outcomes\par databases that will faciliate hypothesis-driven analyses of these resources,\par The RTOG's research is primarily directed toward patients with brain tumors, head and neck cancer, lung\par cancer, gastrointestinal cancer, and genitourinal cancer. More limited research strategies have been\par developed for patients with gynecologic and breast cancer and sarcoma. RTOG research is supported by\par outstanding contributions from the Advanced Technology Integration, the Translational Research Program,\par and the Health Services Research and Outcomes Committees as well as the newly relocated Biospecimen\par Resource and from the four core committees of Medical Oncology, Medical Physics, Pathology, and Surgical\par Oncology. These contributions are well coordinated by a strong administrative and scientific infrastructure\par and have resulted in increased productivity in the current as compared with the prior funding cycle in terms\par of: 1. publication record; 2. clinical trials activated and completed; 3. overall patient accrual; 4. public and\par private funding of group research; 5. collaboration with other cooperative groups and other NIH-funded\par organizations; and 6. increased participation and leadership of Canadian investigators, with 8 of 37 full\par member institutions being Canadian, Close to two-thirds of all cancer patients receive radiation therapy for\par cure or for symptom relief. Novel technology, molecular targeted drugs and advances in radiation and cancer\par biology will improve the success rate of radiation therapy through clinical research over the next six years.\par \par }